Extension of Type 2 Diabetes Genetic Clustering to Populations of non-European Ancestry

Abstract
In the United States, populations of non-predominantly European ancestry, such as African Americans and
Hispanic-Latinos, are disproportionately afflicted with type 2 diabetes (T2D) and T2D-related complications, but
are also traditionally under-represented in medical research, particularly genetic studies. There are
appreciated, but as yet unexplained, differences in T2D clinical characteristics between populations; for
example, at a given body mass index, individuals of Asian ancestry having a higher prevalence of T2D and
increased visceral adiposity compared to individuals of European ancestry. Furthermore, several important
T2D loci have been identified in non-European populations, such as SLC16A11, which is common in Latin
Americans and essentially absent from individuals of European ancestry. We recently performed cluster
analysis of T2D-associated genetic variants and T2D-related traits, resulting in five groupings of T2D genetic
loci based on the T2D genetic-variant-trait associations (Udler et al, PLoS Medicine 2018). The clusters were
readily interpretable: two related to mechanisms of insulin deficiency and three related to mechanisms of
insulin resistance. These analyses, however, were restricted to studies in populations of European ancestry
due to data availability at the time, but newer genetic studies and datasets are now accessible. We would like
to extend the cluster analysis to groups of non-European ancestry in order to elucidate genetic mechanism of
disease and generate results that are more widely translatable. In Aim 1 we will perform phenotypically
informed cluster analysis of T2D genetic variants using study populations of non- European ancestry (African,
East Asian, Hispanic/Latino, and South Asian) to identify T2D mechanistic pathways. In Aim 2, we will utilize
the genetic clusters generated in Aim 1 to construct cluster-specific polygenetic scores in individuals of non-
European ancestry from validation cohorts (Mass General Brigham Biobank, UK Biobanks, and All of Us) to
determine which clinical characteristics are associated with each cluster-specific polygenic score. The goal of
Aim 2 is thus to use the genetic clusters to inform T2D subclassification. Finally, in Aim 3, we will investigate
whether the relative disease burden conferred by these genetic clusters differs among ancestral populations.
The overarching objectives of this R03 are to improve understanding of T2D pathophysiology, translate
genomic discoveries to useful applications for patient care, and advance T2D genetics research in populations
traditionally under-represented in biomedical research. This proposal will provide necessary preliminary data
for a future R01 study aimed at investigating the physiology of individuals with high burden for T2D genetic
pathways and support more diverse representation in future research.

Public health relevance
Project Narrative Type 2 diabetes prevalence continues to rise globally, and its biological basis remains incompletely understood limiting effective management. We have recently utilized inherited genetic discovery to identify predominant genetic pathways of disease, which could support identification of disease subtypes and aid drug development. Our previous work was limited to populations of European ancestry due to availability of large-scale genetic studies, and we now propose to develop and apply genetic clusters involving variants from populations of non- European ancestry.